A Model for Nephronophthisis in Caenorhabditis elegans

DESCRIPTION (provided by applicant): Nephronophthisis (NPHP) is the most common genetic cause of end stage renal disease in infants, children, and young adults. NPHP is caused by a mutation in one of at least nine different genes (NPHP1 - NPHP9), accounting for less than 50% NPHP cases and indicating that many other disease loci remain unidentified. NPHP and other cystic kidney diseases are associated with defects in cilia. While the NPHP gene products (the nephrocystins) are localized to cilia, their functions in this sensory organelle remain largely unknown. The nematode Caenorhabditis elegans is a powerful model organism to study the roles of the nephrocystins in their native cellular environment. In C. elegans, NPHP-1 and NPHP-4 act globally to modulate ciliary development and morphogenesis in a cell-type specific manner. Human and worm nephrocystin-1 and nephrocystin-1 localize to the transition zone of cilia on renal epithelial cells and sensory neurons, respectively, suggesting an evolutionarily conserved role. Proposed studies in Aim 1 will define how NPHP-1 and NPHP-4 function at the ciliary transition zone. Proposed studies in Aim 2 will determine the role of the C. elegans NPHP2, NPHP8, and NPHP9 homologs. Proposed studies in Aim 3 will reveal genetic and functional interactions between the NPHP genes and known ciliopathy disease gene homologs. An understanding of human ciliary diseases such as Nephronophthisis relies on a complete understanding of ciliary components and of complex genetic and developmental interactions with modifier loci. These proposed studies will broaden our understanding of the nephrocystins and cilia biology at the genetic, molecular, cellular, and organismal levels. Such understanding is essential in order to identify the functions of the NPHP genes, their role in disease processes, and their potential as therapeutic targets.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cilia are motile or sensory organelles found on almost every non-dividing human cell. The mechanism of ciliary development is evolutionarily conserved in organisms ranging from alga, worms, flies, fish, mouse, to human. Recent studies have revealed that defects in cilia are linked to human cystic kidney diseases such as Nephronophthisis (NPHP), autosomal dominant polycystic kidney disease (ADPKD), autosomal recessive PKD, Bardet-Biedl Syndrome (BBS), and Meckel Gruber Syndrome (MKS). The nematode Caenorhabditis elegans is an exceptional animal model system for the study of cilia-related human disease genes. Many of the genes required for the formation, maintenance, and function of C. elegans cilia have human counterparts that, when mutated, cause diseases with renal pathologies. The study is designed to use the powerful molecular genetic tools of C. elegans to model Nephronophthisis, the most common genetic cause of end stage renal disease in infants, children, and young adults. Project Narrative Cilia are motile or sensory organelles found on almost every non-dividing human cell. The mechanism of ciliary development is evolutionarily conserved in organisms ranging from alga, worms, flies, fish, mouse, to human. Recent studies have revealed that defects in cilia are linked to human cystic kidney diseases such as Nephronophthisis (NPHP), autosomal dominant polycystic kidney disease (ADPKD), autosomal recessive PKD, Bardet-Biedl Syndrome (BBS), and Meckel Gruber Syndrome (MKS). The nematode Caenorhabditis elegans is an exceptional animal model system for the study of cilia-related human disease genes. Many of the genes required for the formation, maintenance, and function of C. elegans cilia have human counterparts that, when mutated, cause diseases with renal pathologies. The study is designed to use the powerful molecular genetic tools of C. elegans to model Nephronophthisis, the most common genetic cause of end stage renal disease in infants, children, and young adults. __SpecificAimsTextDelimiter__ A Model for Nephronophthisis in Caenorhabditis elegans A. Specific Aims Nephronophthisis (NPHP) is an autosomal recessive kidney disease and the most common genetic cause of end stage renal disease in infants, children, and young adults. NPHP is caused by a mutation in one of at least nine different genes (NPHP1 - NPHP9), accounting for less than 50% NPHP cases and indicating that many other disease loci remain unidentified. NPHP and other cystic kidney diseases are associated with defects in cilia. While the NPHP gene products (the nephrocystins) are localized to cilia, their functions in this sensory organelle remain largely unknown. The nematode Caenorhabditis elegans is a powerful model system to study the physiological and pathological roles of the nephrocystins in their native cellular environments. This proposal is designed to address important basic questions regarding the function(s) of the C. elegans nphp genes in ciliary development, morphogenesis, specialization, and signaling. C. elegans nephrocystin-1 and nephrocystin-4 homologs have been implicated in signal transduction and localized to the ciliary transition zone (TZ), which serves as a boundary between cytoplasmic and ciliary components. We find that nphp-1 and nphp-4 are not required for localizing the ciliary transient receptor potential polycystin-2 (TRPP2) channel PKD-2 and TRP vanilloid (TRPV) channel OSM-9. Instead, NPHP-1 and NPHP-4 act globally to modulate ciliary development and morphogenesis in a cell-type specific manner. Two generalities may be drawn regarding loss of nphp-1 and/or nphp-4. First, there is variable phenotypic expressivity in nphp-1 and nphp-4 mutants. Clinical variability is also observed in NPHP patients. Second, nphp-1 and nphp-4 ultrastructural defects appear not in the TZ but occur principally in the axoneme, raising the question of how these proteins act. In humans and Chlamydomonas, the nephrocystins also localize to the TZ or basal body region. Chlamydomonas IFT52 localizes to the periphery of transition fibers, leading to the proposal that the TZ region serves as shipping and receiving zone. We find that OSM-6/IFT52 physically associates with NPHP-1, NPHP-2/Inversin, and NPHP- 4, and that NPHP-4 and OSM-6 functionally interact to regulate ciliogenesis. We propose that, in some contexts, the nephrocystins act as one functional unit, while in another cellular millieu, one nephrocystin (or subset of nephrocystins) may function independent of the others. We will: 1. Test the hypothesis that NPHP-1 and NPHP-4 form a TZ complex that performs distinct functions based on general and cell-type specific components. A. We will investigate the roles of nphp-1 and nphp- 4 in A-B-tubule stability and ciliary length regulation. B. We will ascertain the physiological relevance of physical associations between NPHP-1, NPHP-4, IFT52/OSM-6 and Nup155/NPP-8 and test the hypothesis that Npp155/NPP-8 functions as a "cilioporin." C. We will examine NPHP-1, NPHP-4, and Nup155/NPP-8 localization at the ultrastructural level using immunogold transmission electron microscopy. 2. To characterize the C. elegans homologs of NPHP2, NPHP8, and NPHP9. We have determined that two NPHP-2 isoforms exhibit localization patterns and mutant phenotypes different from that of NPHP-1 and NPHP-4, hinting at a distinct mechanism of action. To determine the relationship between C. elegans NPHP homologs, we will A. characterize the expression pattern and subcellular localization of NPHP-8 and NPHP-9; and B. define the loss-of-function phenotype of nphp-2, nphp-8, and nphp-9. 3. Identify genes that interact with the nephrocystins. In the C. elegans system, multigenic interactions and multiple pathways may be studied in a fixed genetic background. We will analyze genetic and functional interactions between the nephrocystins and known disease gene homologs (Meckel Gruber Syndrome, MKS; Bardet Biedl Syndrome, BBS; Retinitis Pigmentosa 2, RP2; and Parkin-co-regulated gene, PACRG). An understanding of human ciliary diseases such as Nephronophthisis relies on a complete understanding of ciliary components and of complex genetic and developmental interactions with modifier loci. These proposed studies will broaden our understanding of the nephrocystins and cilia biology at the genetic, molecular, cellular, and organismal levels. Such understanding is essential in order to identify the functions of the NPHP genes, their role in disease processes, and their potential as therapeutic targets.